Aging and Lung Disease: Clinical Impact and Cellular and Molecular Pathways

DESCRIPTION (provided by applicant): This application requests partial funding for the 2014 Pittsburgh-Munich Lung Conference entitled Aging and Lung Disease: Clinical Impact, and Cellular and Molecular Pathways. The conference will be held on October 23-24, 2014, at the University Club in Pittsburgh, PA. Expected attendance is 300-400 and will include basic scientists, physician-scientists, clinicians, and other health professionals. Speakers and attendees will be junior and senior investigators as well as trainees specializing in a wide range of scientific disciplines (cell biology, genetics, medicine, pulmonary, geriatrics, public health). This Conference represents the 13th annual Pittsburgh Lung meeting with a unique blend of cutting-edge science in the field of pulmonary diseases and aging. The specific topics to be covered in this conference include: (1) OMICS of aging; (2) Age, genetics and lung diseases; (3) Molecular drivers of cell aging, and their impact in the respiratory system; (4) Mitochondria and aging; (5) Lung diseases and aging; (6) Aging stem cells and lung repair. We believe that this meeting is unique, timely, and highly important because it will bring together recognized experts within the aging-cell biology, genetics, pulmonary, geriatrics communities in a venue designed to both disseminate new information and to promote the interaction of established and junior investigators. This meeting will provide a framework for novel approaches and directions for future age-related lung diseases research.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application requests partial funding for the 2014 Pittsburgh-Munich Lung Conference entitled "Aging and Lung Disease: Clinical Impact and Cellular and Molecular Pathways." The US population age 65 years and over has increased from 35 million in 2000 to 41.4 million in 2011, and is projected to increase to 79.7 million by 2040. Similar to other organs, biological aging in the lung is associated with structural changes leading to a progressive decline in function. In concordance, the incidence and prevalence of age-related lung diseases such as interstitial pulmonary fibrosis and chronic obstructive pulmonary disease are increasing. Elucidating the molecular mechanisms of lung aging are essential to understand the drastic decline in lung function with age and how aging relates to the development and progression of acute and chronic lung diseases. Although our understanding of the biology of aging has advanced remarkably in the last two decades, few molecular mechanisms linking aging to age-related pulmonary diseases have been identified. The 2014 Pittsburgh Lung Conference will highlight both clinical innovations that affect treatment strategies and could improve patient outcomes as well as research advances that will drive the development of new therapeutic and diagnostic approaches to age-related lung diseases. The conference brings together top scientists from multiple disciplines and institutions to advance this vital field while striving fo an inclusive meeting that actively involves junior scientists. (End of Abstract)